EVOLVE: Emulated trial of the VOice study for improving pain and reducing Long-term opioid use for VEterans

Background: Chronic pain is a major public health problem and a leading cause of disability among Veterans.
As such, addressing chronic pain and opioid safety remain top priorities of the Veterans Health Administration
(VHA). While long-term opioid therapy (LTOT) for chronic pain is common, harms of continuing LTOT may
outweigh benefits for many patients. When this is the case, guidelines recommend tapering or discontinuing
opioids; however, recent evidence also highlights the potential harms associated with tapering or discontinuing
opioids. Furthermore, guidelines emphasize the importance of optimizing non-pharmacologic pain treatment
(NPT) options, yet clinicians report several barriers to doing so. For these reasons, managing chronic pain
among patients prescribed LTOT is often challenging and there is a critical gap in evidence-based strategies to
overcome these challenges. To address this gap, the Veterans Pain Care Organizational Improvement
Comparative Effectiveness (VOICE) study compared two models of care to improve pain and support opioid
tapering. This 10-site pragmatic trial enrolling from 2017-2021 randomized 820 veterans with moderate to
severe pain treated with LTOT to two active collaborative care interventions with on average ten study contacts
over a 12-month period; VOICE did not have a control group or usual care condition. While both groups
improved, the VOICE study found no differences in pain-related outcomes or changes in opioid dose
between its two interventions. Thus, a lack of control condition leaves unanswered questions about the
impact of these interventions as compared to usual primary-care based VHA pain care.
Methods: To address these unanswered questions and help inform VA’s decisions about pain care resource
deployment, our overarching aim is to emulate a 3-arm, randomized controlled trial. Emulated trials draw on
observational data to emulate the design characteristics of a randomized trial when randomized trial data is not
available. In the proposed emulated trial, we will examine the impact of VOICE’s two active interventions
against a retrospectively matched “external” usual care control group using a propensity-based matching
approach. This control group will be drawn from the Evaluating Prescription Opioid Changes in Veterans
(EPOCH) study, a national longitudinal prospective cohort launched in 2016 and funded by VA Health Services
Research & Development (HSR&D) to understand effects of changes in opioid prescribing practices on
Veterans treated with LTOT for chronic pain. EPOCH’s large, nationally representative sample (N=9253),
nearly identical timeframe, inclusion criteria and study populations, and similar patient-reported and electronic
health record outcomes to VOICE make it a very compelling source of patients prescribed LTOT receiving
usual VHA pain care.
Specific Aims: By emulating a three-arm RCT and examining outcomes including pain-related interference,
opioid dose, quality of life, and engagement in non-pharmacological pain treatments, we will answer important
questions about implementation of treatments and approaches across VHA to enhance pain care. Thus, Aim 1
is to compare the collaborative care (active) interventions from the VOICE study to a matched usual care
control group drawn from the EPOCH cohort on the primary outcome of pain-related interference and
secondary outcomes of opioid dose reduction, NPT uptake and health-related quality of life. In Aim 2, we will
compare collaborative care (active) interventions from the VOICE study to a matched usual care control group
drawn from the EPOCH cohort on primary and secondary outcomes from Aim 1 among pre-specific high-risk
subgroups. Finally, in Aim 3, among those who tapered opioid dose, we will compare patient-reported rates of
harms (i.e., worsening pain and quality of life) in the collaborative care (active) interventions from the VOICE
study to a matched usual care control group drawn from the EPOCH cohort.

Public health relevance
While long-term opioid therapy for chronic pain is common, harms of continuing it may outweigh benefits for many patients and tapering may be recommended; however, recent evidence also highlights potential harms associated with tapering or discontinuing opioids. Limited data exists on strategies for patient-centered opioid tapering and managing chronic pain among patients prescribed long-term opioid therapy. To address these unanswered questions and help inform VHA’s decisions about pain care resource deployment, our overarching aim is to emulate a three-arm, randomized controlled trial where we will compare two active interventions to a matched usual care group on the primary outcome of pain-related interference and secondary outcomes of opioid dose reduction, uptake of nondrug pain treatment, and health-related quality of life. We will also examine outcomes for pre-specified high-risk subgroups and, among patients who tapered opioid doses, will compare rates of patient-reported harms (namely, worsening pain and quality of life).